Project 3: Targeting Stress-induced MK2 as Novel Strategy in Pancreatic Cancer

PROJECT SUMMARY
We propose a phase 1 clinical trial to test the safety and preliminary efficacy of a new therapeutic strategy that
aims at augmenting the efficacy of standard chemotherapy in pancreatic cancer. To date, combination
chemotherapies remain the mainstay treatment of pancreatic cancer. FOLFIRINOX is a combination
chemotherapy regimen with the best track record for treatment of pancreatic cancer that cannot be treated with
surgery; however, even with the best treatment, the majority of the patients will still succumb to the disease
within one to two years of diagnosis. This is in part due to pancreatic cancer cells developing resistance to the
chemotherapy drugs. Another reason for poor survival and unsuccessful clinical experience of immunotherapy
is because of the dense non-cancer cells that surround the pancreatic cancer not only prevent the chemotherapy
drugs from reaching the cancer cells, but also incapacitate anti-tumor immune cells. These challenges support
the need for further research into overcoming resistance to combination chemotherapy and improving the effect
of immunotherapy in pancreatic cancer.
Using an unbiased protein array analysis, we found that pancreas cancer cells dramatically upregulate MK2
enzyme and its partnering molecule Hsp27, when exposed to FOLFIRINOX chemotherapy. Both MK2 and Hsp27
protect pancreas cancer cells from cell death when their DNA is hit by chemotherapy. When MK2 was blocked
by ATI-450, pancreatic cancer cells became much more vulnerable to chemotherapy-induced death. In an
aggressive pancreas cancer mouse model (KPC mice), the combination of ATI-450 plus FOLFIRINOX potently
ablated the cancer, an observation that to our best knowledge, has not been reported. Furthermore, ATI-450
causes immune cells surrounding the cancer to be converted to the types that were more susceptible to
immunotherapy, paving the way for development of an immunotherapy regimen, which we will establish in this
proposal. Importantly ATI-450 is now already in clinical trial for patients with moderate to severe rheumatoid
arthritis and is very well-tolerated except for infrequent, mild dizziness and headaches, which lessens our
concerns of added toxicities when combined with FOLFIRINOX.
In this proposal, we will conduct a phase I clinical trial to establish the safety of combining ATI-450 with
FOLFIRINOX in patients with inoperable pancreatic cancer (Aim 1). We will determine a safe, tolerable dose of
ATI-450 in combination with FOLFIRINOX and get an early indication on whether this combination is more
effective than FOFIRINOX alone. We plan to obtain tumor and blood samples in patients who are receiving ATI-
450 and FOLFIRINOX on this trial and analyze those to confirm that the addition of ATI-450 was useful to
overcome the resistance to FOLFIRINOX, and changed the immune cells surrounding the cancer, as it did in
animal models (Aim 2). Lastly, we made discovery that MK2 activates anti-cancer immunity. By analyzing patient
samples treated with MK2 inhibitor and generating new state-of-the art genetic mouse models, we will investigate
the mechanism and develop a novel MK2 inhibitor-based immunotherapy strategy for pancreatic cancer (Aim
3).

Public health relevance
PROJECT NARRATIVE Extreme resistance to chemotherapy is one of the major factors that underlies the poor prognosis of pancreatic cancer. Using an unbiased protein array analysis, we have identified a novel mechanism of resistance governed by MK2 kinase, that when overcome, renders chemotherapy effective. In this study we propose to conduct a phase 1 clinical trial combining a novel MK2 inhibitor ATI-450 with FOLFIRINOX chemotherapy for patients with metastatic pancreatic cancer and to develop a novel immunotherapeutic strategy that can be tested in the future.